MAOI-inspired activity probes to translate epigenetics and genetics into drugs

Project Abstract
Identification of genetic and epigenetic changes associated with disease states can afford
deep insight into the underlying molecular processes, but, particularly for diseases of the central
nervous system (CNS), translating this information to new drug therapies remains a challenge.
Here, we will exploit the chemistry of pharmacophores found in psychoactive drugs to study the
impact of genetic variants and epigenetic modifications in addiction. Hydrazine-based drugs
including monoamine oxidase inhibitors (MAOI) have a long history of success in treating CNS
disorders. The hydrazine group covalently inactivates several classes of enzymes (e.g. oxidases,
oxygenases, demethylases, hydroxylases) in the CNS that participate in transcriptional regulation
and chromatin remodeling, thereby contributing to a broad range of biological functions and
disease pathologies. I previously developed a novel chemical proteomics discovery platform
(which I dubbed `RP-ABPP) by exploiting the unique reactivity (reverse polarity, RP) of this
pharmacophore to create unbiased probes to target these enzyme classes by activity-based
protein profiling (ABPP). Given the established ability of hydrazine drugs to reach the CNS and
manipulate its biochemistry, this project will implement first-in-class, nucleophilic brain-
penetrating probes using our RP-ABPP platform to discover hydrazine-sensitive enzymes
disrupted in preclinical models of drug addiction. Specifically, these probes will evaluate changes
to the brain during the development of dependence using electronic nicotine delivery systems
(ENDS) with a newly established mouse model of inhalation exposure. The goals are to i) identify
novel druggable enzyme targets that are dysregulated in nicotine dependence and ii) develop a
suite of selective probes that can be used by neuroscientists as pharmacological tools to study
drug abuse and other psychiatric disorders. This platform is expected to i) create new
opportunities to map functional consequences of genetic mutations and epigenetic modifications
in drug dependence, ii) discover new druggable enzyme activities that can be spatially mapped
by imaging, and iii) ultimately create a unique opportunity for therapeutic development around a
relatively underexplored chemical space.

Public health relevance
Supplement Narrative other we impact genetic- and epigenetic-level insights into therapies that treat substance abuse and diseases of the CNS while retaining anti-addictive properties remains a major challenge . Here, will exploit the chemistry of anti-addictive pharmacophores found in psychoactive drugs to study the of genetic variants and epigenetic modifications in CNS diseases. Translating Measuring changes in protein activity in mouse models of CNS diseases will identify targets of anti-addictive drugs to treat this growing epidemic.